ASSURE Advanced Radiological Sciences Program

Advances in radiological sciences that respond to the complexity of cancer continue to expand exponentially
with the integration of groundbreaking technologies such as (i) artificial intelligence (AI) throughout all cancer
care, (ii) advanced imaging systems at the single quantum detection level, (iii) an explosion of combination
therapies and radiopharmaceuticals as both imaging and therapeutic agents, and (iv) precision medicine for
individualized treatment. To respond to this rapidly changing landscape, graduate programs in medical physics
face significant challenges to train cancer researchers with scientific and technological skills to harness the
potential of these emerging innovations. To address this critical need, we established the Academic Summer
Student Undergraduate Research Experience (ASSURE) in Advanced Radiological Sciences at the University
of Wisconsin-Madison (UW). ASSURE’s long-term objective is to equip future cancer researchers with the
necessary skills to launch a successful scientific career through comprehensive undergraduate research
experiences. Moreover, ASSURE addresses current barriers that limit the recruitment and retention of a diverse
cancer research workforce, thereby enabling us to propel cancer research forward to redefine the technological
landscape of what is possible in cancer diagnosis and treatment. To achieve this, we propose the following
specific aims: Aim 1) Establish an immersive summer research experience in the radiological sciences. Through
proactive outreach, we will recruit a diverse cohort of 17 undergraduate students that will participate in cancer-
focused scientific training, including didactic lectures, mentored research experiences within laboratories, and
interactive laboratory tours, culminating with a trainee symposium to showcase research accomplishments and
provide community engagement. Aim 2) Implement a professional educational curriculum for mentees and
selected mentors as facilitators, via structured training that complements the research experience. We have
partnered with the Wisconsin Institute for Science Education and Community Engagement (WISCIENCE) at UW
to i) provide ASSURE participants with a sustainable framework for professional development, ii) train ASSURE
faculty in effective mentoring strategies, and iii) collect structured feedback and assessments of our program’s
longitudinal improvement and successes. Aim 3) Quantify the sustained and measurable impact of ASSURE.
We will assess the program at multiple endpoints, starting with intake and outcomes surveys while leveraging
multi-layer assessment via faculty and an advisory board. We will establish an outcomes database to track career
trajectories of ASSURE alumni and maintain long-term engagement activities for iterative program improvement.
Overall, ASSURE incorporates state-of-the-art research experiences with unparalleled resources and
complementary professional education to achieve our mission: to prepare the next generation of technologically-
versed researchers while responding to the need of a diverse workforce to innovate and create new approaches
to cancer diagnosis and treatment, with the overarching goal of improving outcomes in cancer patients.

Public health relevance
The increasing complexity of cancer care requires innovative approaches and bridging technological gaps. The Academic Summer Student Undergraduate Research Experience (ASSURE) in Advanced Radiological Sciences at University of Wisconsin-Madison will cultivate a diverse pool of researchers equipped to navigate advanced technologies via research immersion and career development.